Effects of the oral microbiome on Adverse Outcomes of Pediatric Hematopoietic Cell Transplantation

ABSTRACT:
Dental clearance, to assure the absence of dental caries, is a routine process prior undergoing hematopoietic
cell transplant (HCT). Dental caries is one of the most prevalent childhood diseases worldwide, affecting 25-50%
of children in the United States, and in preliminary and published studies, we have found a surprising association
between the presence of active dental caries prior to transplant, and risk for blood stream infection (BSI) in
pediatric
hematopoietic cell transplant (HCT) recipients.
BSI is a life-threatening condition associated
with significantly worse clinical outcomes, and therefore we propose to further understand the association
between the cariogenic oral microbiome and translocation of microbes to the blood stream of in pediatric HCT
recipients
. We propose to test the hypothesis that oral microbes in children undergoing hematopoietic cell
transplant, can be translocated to the blood stream, and are associated with adverse outcomes. We will test this
hypothesis through 2 specific aims. Aim 1 will
determine the relationship between dental treatment and the
cariogenic oral microbiome prior to admission, and adverse effects related to the translocation of oral microbes
to the blood stream in children undergoing HCT. Aim 2 will identify interkingdom networks in the oral and blood
microbiome of pediatric patients over the course of HCT therapy, related to their pre-transplant caries status. To
achieve these aims we will recruit pediatric patients
from the UCSF pediatric Bone & Marrow Transplant unit at
UCSF Benioff Children’s Hospital. Oral samples including supragingival plaque and saliva, will be collected at
the time of admission, post-conditioning, and post- transplant. Blood samples will be collected at the time of
admission and post-conditioning. Blood microbes will be compared to oral microbes following shotgun
metagenomic sequencing, and assessed for their association with adverse treatment outcomes including fever,
mucositis, and BSI.
Taxonomic and functional modules of the cariogenic microbiome that are altered through
the course of HCT will be characterized by shotgun metagenomic sequencing
, and compared in pre-HCT caries-
active and caries-free subjects. We will
expand the current oral microbiome paradigms beyond bacteria to
include fungi, viruses and archaea and their relationships in the context of dental caries risk in HCT. We expect
that the unique function and location of the cariogenic oral microbiome on tooth surfaces, may enhance survival
of these microorganisms from the effects of chemotherapy drugs and antibiotics, to facilitate microbial
translocation to the blood stream. Our findings will provide a foundation for the development of rationally
designed oral care programs aimed at reducing morbidity in this highly vulnerable population.

Public health relevance
Project Narrative This exploratory study will investigate the interkingdom interactions of the pediatric oral supergingival plaque microbiome and its effect on comorbidity of hematopoetic cell transplant. Shotgun metagenomic sequencing will be done to compare oral bacteria, archaea, fungi and viruses before and after transplant to identify functional modules/networks in the oral microbiome that differentiate caries risk and markers of blood infection in pediatric HCT recipients.